Cellular mechanotransduction - from the immune response to transcriptional regulation

The overall goal of the research in my lab is to define the molecular mechanisms and functional consequences
of cellular mechanotransduction – or how cells sense the mechanical properties of their microenvironment and
launch appropriate functional responses. Cell-cell interactions, mediated by adhesion and signaling receptors,
are highly dynamic and subject to cytoskeletal movements that impart substantial mechanical force at the
interface. How cells combine mechanical and biochemical signals to carry out specific functions is not well
understood. Our lab tackles this question in two contexts – the immune response in T cells and regulation of
gene expression - using a combination of high (and super)-resolution imaging, force measurements,
quantitative image analysis, genomics and mathematical modeling. As part of our NIGMS-funded research, we
have recently demonstrated that T cell activation requires a close coordination of the actin and microtubule
cytoskeletons in order to generate forces at the T cell receptor, which are transduced to biochemical signaling
leading to T cell activation. We have shown that cytokine stimulation leads to modulation of cytoskeletal
dynamics and force generation in cytotoxic T cells, facilitating the cytolytic response. We have also developed
new methods for analysis of single molecule tracking data, which we have applied to study the dynamics and
binding kinetics of transcription factors and relate them to genome-wide measurements. Over the next five
years, we plan to continue to address the molecular mechanisms that mediate actin/microtubule crosstalk in T
cells for the control of RhoA-mediated forces and how these cytoskeletal forces tune the mechanical
coordination of cytotoxic T lymphocyte activation and their efficacy in killing cancer cells. Taking advantage of
the flexible nature of the R35 funding mechanism, we will establish a new line of research that builds on our
technological capabilities to examine how mechanical cues are relayed to the nucleus to regulate gene
expression in a functionally appropriate manner and how mechanical cues interact with tissue-specific cues.
We will use advanced tools for real-time visualization of nuclear hormone receptor and target gene
transcription dynamics to interrogate 1) how substrate stiffness regulates chromatin accessibility and
modulates the mobility of transcription factors and co-activators, with a particular focus on nuclear hormone
receptors and 2) how biophysical mechanisms transduce changes in the mechanical environment into
alterations in gene expression dynamics. Our research program will 1) elucidate how mechanical stimuli and
biochemical signaling are coupled to orchestrate the adaptive immune response and 2) enable fundamental
understanding of how mechanical properties of the microenvironment modulate gene expression, with
implications for designing new targets for intervention in immune therapy and breast cancer.

Public health relevance
Recent studies have indicated that mechanical cues from the cell's environment are indispensable for key processes such as development and wound healing. Changes in the mechanical properties of tissues are reliable markers of disease – for example tissue density is one of the strongest risk factors in cancer progression, while immune cells exploit mechanical signals to kill cancer cells. How mechanical cues regulate cell function remains poorly understood. The proposed research to develop fundamental understanding of how mechanical stimuli and cell generated forces regulate T cell signaling and killing of tumor cells as well as the dynamics of gene expression will have important implications for the development of new therapeutic avenues for immunotherapies and diagnostic tools for diseases like breast cancer.